Brain Injury Outpatient Education and Care Navigation -Supplement

PROJECT SUMMARY
Celeste Garcia’s long-term goal is to become a research-scientist with a focus on implementation science
directed to the needs of the Latinx/Hispanic community. She proposes two years of research and career
development activities under mentoring of Drs. Nathalia Jimenez (PI for the parent grant and primary mentor
for the diversity supplement), Ramirez, Ko and Zhou. Career development and training activities include
comprehensive literature review, coursework, and mentoring directly relevant to the proposed research project.
The primary research activity takes advantage of the multicenter design of the 1stBIEN parent grant. The
diversity supplement proposes two complementary projects that explore inner and outer setting domains of the
Consolidated Framework for Implementation Research (CFIR) related to the Latinx population. Study 1
assesses in real time implementation related domains of the 1stBIEN intervention at each of the participant
sites. Study 2 evaluates outer context by pilot testing a population level measurement of socioeconomic
disadvantage (The Area Deprivation Index ADI) as an independent predictor for post-TBI health care utilization
and functional outcomes among Latinx/Hispanic children; and evaluate its effect on the response to the
1stBIEN intervention. This proposal uses mixed methods. Study 1 uses in depth interviews and thematic
analysis grounded on CFIR to identify barriers and facilitators for program implementation of 1stBIEN core
components and modifications in peripheral components to accommodate for institutional needs. Study 2 uses
bivariate analysis examining the correlation coefficient between ADI and treatment adherence, and ADI and
post-TBI function. To test if ADI modifies the intervention effects, subsequent linear regression models test the
association between treatment adherence and post-TBI function and ADI, while controlling for intervention and
baseline TBI severity. Findings from this study can facilitate prioritization of at-risk populations and strategies
for institutional implementation of patient centric bilingual programs.

Public health relevance
PROJECT NARRATIVE Translating evidenced-based patient centric interventions to clinical settings require understanding of inner- institutional and outer community contextual factors. The goal of this diversity supplement is to evaluate in real- time contextual factors in the implementation of a bicultural/bilingual navigation program for Hispanic children with traumatic brain injury. Identifying institutional and community contextual barriers and facilitators can inform strategies to effectively adopt interventions aimed to Hispanic Children.